Sub-cellular Targeting of Endothelial ROS in Myocardial Ischemia

renewal application is based on the novel findings that reduction in mito-ROS, using genetic
manipulation and/or nanoparticle drugs, improve survival and proliferation of coronary EC and help recover
cardiac function in a post-myocardial infarct (MI) animal model and human atrial tissue. Preliminary findings
in the current application demonstrate that reduction of mito-ROS using transgene (MnSOD) and nanodrugs
(JP4-039, XJB5-131) induce mitochondrial complex I biogenesis (proteomic and phosphoproteomic data)
and oxidative phosphorylation (Ox-Phos) in EC resulting in coronary angiogenesis cardiac function recovery
in post-MI heart.
This innovative
EC, like most tumor cells, utilizes anerobic glycolysis as a major (85%) source of ATP
Thus, the shift from less-
efficient energy production system glycolysis (2 ATP/glucose molecule), to a more efficient Ox-Phos (34-36
ATP/glucose) may provide critical energy support to EC needed during ischemia (low glucose, oxygen). Here,
we propose to examine a novel overarching hypothesis that modulation of mito-ROS improves
production, while EC mitochondria are mostly involved in dNTP biosynthesis.
Δψm and
‘super-complex’ (SC) formation resulting in efficient electron transport chain (ETC) and Ox-Phos-mediated
ATP generation in EC during ischemia. This shift from
glycolysis to a more efficient mitochondrial Ox-Phos
may provide resilience/survival to coronary EC during ‘energy crisis’ in myocardial ischemia.
The therapeutic
benefit of intervening on subcellular ROS level will be best realized by specific down regulation of mito-ROS
in ECs that have been exposed to ischemia/hypoxia. This hypothesis will be fully tested in vivo using our
novel EC-specific transgenic MnSOD (SOD-OE; mitochondrial antioxidant) animals and supported using
mitochondria-specific nitroxide and nanoparticle antioxidant in large animal model (swine) and in coronary
vessels from CVD patients undergoing cardiac surgery. We propose three Specific Aims. Aim 1: Elucidate
the molecular mechanisms by which modulation of mitochondrial ROS protect coronary EC from oxidative
stress and induce coronary angiogenesis during myocardial ischemia. Using SOD-VE transgenic animals
and myocardial infarct-mimicking (LAD ligation) surgeries, Δψm, super-complex (SC) formation, oxygen
consumption rate (OCR) versus extracellular acidification rate (ECAR), ATP synthesis, will be assessed. Aim
2: Determine the effects mitochondria-targeted MnSOD-mimetic (JP4-039, XJB-5-131) nanoparticles on
post-infarct vessel density and recovery of cardiac function in mice and on chronic myocardial ischemia in
large animals (swine). Aim 3: Elucidate the molecular mechanisms by which mitochondrial antioxidant
nanoparticles (JP4-039/XJB-5-131) improve angiogenic potential of human coronary vessels (from cardiac
surgery patients) ex vivo. This study using unique animal models, human atrial tissue, and mitochondria-
specific antioxidant will provide novel insights into the mechanisms by which mito-ROS can improve EC
survival and angiogenesis by recruiting mitochondria as an efficient energy generator during ischemia.

Public health relevance
Project Narrative The number of blood vessels that are preserved and/or formed after myocardial infarction (heart attack) is a crucial factor that determines survival and morbidity of the patient. This innovative project will examine whether a shift of endothelial cells (EC) from glucose- dependent glycolysis to mitochondrial oxidative phosphorylation for their energy supplies (ATP) by modulating mitochondrial oxidant levels can improve viability and proliferation of coronary vascular endothelium in ischemic myocardium. The outcomes will help develop treatment regime for coronary artery disease, heart attack, and also stroke in the long-term.